Unraveling the function of CD276

Our laboratory studies the role of transmembrane proteins overexpressed in tumor-associated stromal cells, and one of the major proteins we focus on is CD276. Surface proteins like CD276 are of interest because they are readily accessible to blood-borne therapeutics. To understand the functional role of CD276 in vivo, our laboratory exploits genetically engineered mouse models. Using these models we aim to unravel the role of CD276 in tumor growth. We have also disrupted CD276 in cancer cell lines using CRISPR/Cas9 to explore the role of CD276 in tumor cells on tumor growth. These studies are helping us to better understand the functions of CD276 under both normal and pathological conditions.